Regulation of Retinal Gap Junctions

Neurons throughout the central nervous system employ two types of synapses, chemical and electrical,
to communicate. Electrical synapses, made from gap junction channels, support fast, bidirectional and
transmitterless signal transfer between cells that organizes neurons into networks and forms defined and
sometimes specialized circuits. Both chemical and electrical synapses display plasticity, which is an
essential substrate for local circuit optimization and plays a critical role in learning, behavior and sensory
signal processing. The majority of electrical synapses in the mammalian central nervous system are
formed by Connexin 36 (Cx36), the product of the GJD2 gene. This connexin is intrinsically capable of
functional plasticity through variations in phosphorylation that open or close the channels, and so is
dynamically regulated by cellular signaling at the location of the electrical synapse. This project seeks to
understand the mechanisms that control this plasticity in neurons of the retina, in which Cx36 plays central
roles in rod pathway signal flow and in adaptation of many circuits to different light levels. In chemical
synapses, many proteins that regulate function and turnover of neurotransmitter receptors are assembled
in the post-synaptic density. In an analogous manner, many proteins that regulate the function of
electrical synapses are assembled near them, but our knowledge of these assemblies is minimal. In this
project, we will identify proteins that regulate the function and turnover of Cx36 electrical synapses
through proteomic strategies. We will harness evolutionary conservation of regulatory mechanisms to
identify proteins found to be associated with Cx36 in both mouse and zebrafish retina, and investigate
the roles of novel proteins discovered in regulation of Cx36 plasticity and turnover. Key elements of
assemblies associated with the electrical synapse are scaffold proteins, which are required for electrical
synapse formation and stability. However, our studies indicate that a critical scaffold that binds to Cx36
inhibits its channel function when bound, but that binding to Cx36 is weak. We will investigate the
hypothesis that Cx36 is evolutionarily tuned to bind weakly to certain scaffolds and that binding can be
further weakened by phosphorylation of sites on Cx36, allowing it to dissociate and enter functional
states. Finally, we will investigate whether this modification of Cx36 binding to associated proteins can
modulate the size of electrical synapses in a manner that correlates with the electrical synapse functional
state. These studies will shed light on mechanisms that regulate the function of electrical synapses in
the vertebrate retina, and will provide insight relevant to electrical synapses throughout the central
nervous system.

Public health relevance
This project seeks to discover molecular mechanisms that control the size and functional state of electrical synapses made of Connexin 36, the protein encoded by the GJD2 gene. Functional regulation of Connexin 36 is central to the eye’s adaptation from dim to bright light, and the GJD2 gene plays an as yet poorly understood role in the development of myopia. This research project will increase our understanding of processes important for both normal and abnormal vision.